Developing an HIV/STI intervention for Foster Youth Using Attachment Theory

DESCRIPTION (provided by applicant): The vast majority of youth in foster care have been exposed early in life to overt physical abuse, sexual abuse, chronic neglect, parental substance abuse and/or have been witnesses to interpersonal violence. These exposures can result in extremely disordered or disorganized attachments with early caregivers, which can greatly impact how they relate to others later in life including sexual partners, health care providers, and important adult mentors. These troubled relationships all have been shown to impact risk of sexually transmitted infections including Human Immunodeficiency Virus (HIV/STI). Indeed, adolescents in the foster care system are at between 2-14 times increased risk of sexually transmitted infections compared with youth in the general population. The candidate's long-term objective is to develop an enhanced behavioral intervention to reduce HIV/STI tailored to the needs of adolescents in foster care. Intervention development will be guided by adult attachment theory and specifically by an understanding of how attachment style (e.g., having an avoidant, anxious or secure style) can impact romantic/sexual, health care, and mentoring relationships and consequently can impact HIV/STI risk. To achieve this objective, the candidate will pursue didactic and experiential training to improve knowledge and skills in three specific areas: 1) techniques to assess mediational relationships commonly used in behavioral HIV/STI research, 2) application of adult attachment theory including the use of this theory to improve HIV/STI prevention efforts among adolescents in foster care, and 3) techniques in community-based intervention development that are relevant to HIV/STI prevention research in adolescents with histories of early adverse exposures. The candidate has identified two mentors with complementary expertise in HIV/STI research (Dr. Jane Simoni) and research involving youth in the child welfare system (Dr. Mark Courtney). Additional mentoring will be provided by consultants with expertise in mediational analysis techniques, adult attachment theory, community-based research, bioethics, and biostatistics, and will also include a national expert on community-based HIV/STI research in high-risk adolescent populations (Dr. Ralph DiClemente). The three inter-related studies proposed in this application build on the candidate's training goals and will each contribute to an improved understanding of how adult attachment theory can be applied to develop an enhanced intervention that involves the promotion of healthy relationships to reduce HIV/STI risk among adolescents in the foster care system. The specific aims are to: 1.) conduct a quantitative analysis using an existing longitudinal dataset to understand how relationship factors (e.g., influences of attachments with romantic partners, health care providers, and non-parental adult role-models) mediate the association between attachment style and sexual risk for youth in foster care; 2.) use qualitative methods to elucidate the factors that can directly promote healthy sexuality and HIV/STI-protective behaviors among foster youth in foster care with different attachment styles; and 3.) develop and pilot an enhanced HIV/STI intervention for youth in foster care that includes components that utilize an understanding of adult attachment style to promote healthy romantic/sexual relationships, health care and mentoring relationships. The excellent research environments provided by both Seattle Children's Hospital Research Institute and the University of Washington, as well as the candidate's strong existing relationships with two community partners - the YMCA of Greater Seattle's Center for Young Adults and the Washington State Department of Health and Social Services agency - will enhance the candidate's training and facilitate project goals. After obtaining training, experience, and skills through this K23 Award, the candidate will be prepared to pursue funding to conduct a larger randomized controlled trial of an intervention to reduce HIV/STI risk among youth in the foster care system.

Public health relevance
PUBLIC HEALTH RELEVANCE: This proposal will result in the development of a tailored intervention to reduce the risk of sexually transmitted infections including Human Immunodeficiency Virus (HIV/STI) for adolescents in the foster care system. Youth in foster care have between 2 and 14 times increased odds of several STIs compared with youth in the general population. This application therefore represents an important opportunity to address a priority of Healthy People 2010, the reduction of HIV/STI risk, in an extremely vulnerable population while providing an early career investigator with the tools necessary to launch a productive career in behavioral HIV/STI research. Project Narrative This proposal will result in the development of a tailored intervention to reduce the risk of sexually transmitted infections including Human Immunodeficiency Virus (HIV/STI) for adolescents in the foster care system. Youth in foster care have between 2 and 14 times increased odds of several STIs compared with youth in the general population. This application therefore represents an important opportunity to address a priority of Healthy People 2010, the reduction of HIV/STI risk, in an extremely vulnerable population while providing an early career investigator with the tools necessary to launch a productive career in behavioral HIV/STI research. __SpecificAimsTextDelimiter__ 4. Research Plan. The vast majority of adolescents in foster system have been exposed to overt physical abuse, sexual abuse, chronic neglect, parental substance abuse and/or have been witnesses to interpersonal violence.7, 16, 63 These exposures can result in disordered or disorganized early attachments with biological and/or substitute caregivers.64-66 The combination of early maltreatment and poor attachments has been associated with permanent changes in brain chemistry67-70 and long-term impacts on relationships with peers, adults, and romantic/sexual partners that extend into adolescence and adulthood.29-32, 56 Youth who have experienced these adversities have a significant risk of physical problems, mental health problems and health risk behaviors in childhood and adulthood.5-7, 16-22 At any given time, 510,000 youth in the United States are in foster care and 47% are between the ages 11 and 20 years,47 the age when many health behavior patterns are formed. In 2008, the Institute of Medicine identified a large gap in effective strategies to reduce risk for these youth and recommended that research focusing on youth in foster care be a funding priority.71 One category of health problems for which youth in foster care are at significantly increased risk are sexually transmitted infections including Human Immunodeficiency Virus (HIV/STI).1, 48 HIV/STI can result in severe physical and psychological impacts and are very costly to society9, 72-76 There are many effective programs to reduce HIV/STI risk in other populations;9 however, very few have been conducted among youth in foster care52, 77, 78 and high-quality studies among this52 and other populations with similar patterns of adverse exposures early in life53-55 have failed to show consistent long-term impacts. HIV/STI prevention efforts for youth in foster care has the potential to be greatly enhanced by the use of a framework that incorporates an understanding of the maladaptive approaches to relationships many of these youth have as a result of their early exposures and experiences with caregivers. In this application I propose, with guidance from my mentors, to develop an intervention to promote healthy relationships and reduce HIV/STI risk among youth in foster care using an approach that retains the core themes and behavioral targets from successful interventions in other populations but also includes an understanding of two maladaptive approaches to relationships that can result from the early adversity and disrupted relationships these youth experience: avoidant and anxious adult attachment styles.29-32, 56 These types of attachment patterns influence the formation of relationships, including romantic and sexual relationshipsthat in turn can increase risk for HIV/STI.26, 27, 58 They also impact the ability to connect with health care providers79, 80 and adult mentors81, 82 which likely decreases access to healthy role models and STI- protective knowledge and skills, further increasing HIV/STI risk. I will conduct 3 research projects in order to develop an intervention that is tailored specifically to the needs of youth in foster care. I will explore the use of the setting which I believe is the most effective in which to deliver and ultimately disseminate this program - an independent living program. Independent living programs are formalized programs delivered through the child welfare system designed to help youth in foster care to experience a healthier transition to adulthood. Several recent studies have indicated a great need for research to determine effective content for these programs.83-85 Because they are integrated into the system with which youth in foster care retain the most continuity and because the transition to adulthood is a key time for relationship building, the use of this platform will afford us the best opportunity to reach these vulnerable youth at a time when I may have great impact. The work proposed in this grant has the potential to significantly impact HIV/STI risk and to positively support these youth in their overall transition to adulthood. It will also afford me the experience and skills necessary to design and conduct a larger randomized controlled trial to determine the efficacy of my enhanced program and launch my career as an independent investigator. A. Specific Aims and Statement of Hypotheses. 1. To conduct a quantitative analysis using an existing longitudinal dataset to understand how relationship factors (e.g., influences of attachments with romantic partners, health care providers, and non-parental adult role-models) mediate the association between adult attachment style and sexual risk for youth in foster care. 2. To use qualitative methods to elucidate the factors that can directly promote healthy sexuality and STI- protective behaviors among youth in foster care with different attachment styles. 3. To develop and pilot an enhanced HIV/STI intervention for youth in foster care that includes components that utilize an understanding of adult attachment style to promote healthy romantic/sexual relationships, health care, and mentoring relationships. In conducting these studies, the overall hypotheses are that both avoidant and anxious attachment styles will be associated with increased risk of HIV/STI. I hypothesize that for youth with either of these attachment styles this risk will be mediated by their relationships with adults and their connection with the health care system. I also hypothesize that several variables related to romantic/sexual partner choice will mediate this relationship. Specifically, I expect that for youth with avoidant attachment styles this relationship will be mediated by an increased number of overall partners and casual partners and that for youth with anxious attachment styles this risk will be mediated by an increased number of overall partners and in engagement in relationships with large age differences. I expect these factors to lead to decreased condom use and an earlier initiation of sexual activity for both of these groups compared to youth with secure attachment styles. Finally, I hypothesize that an HIV/STI intervention for youth in foster care that is informed by an understanding of the influence of maladaptive attachment styles on sexual behaviors will be more successful in reducing HIV/STI- related sexual behaviors than have been previous interventions that have not incorporated this understanding.